LONG TERM TREATMENT OF XEROSTOMIA AND XEROPHTHALMIA ASSOCIATED WITH SJOGREN'S

Pilocarpine HCl (Salagen) as tablets will be studied to determine its efficacy and safety in the treatment of xerostomia and xerophthalmia associated with Sjogren's syndrome. It is a multicenter, open-label long-term maintenance study conducted at approximately 20 sites.